IL13Ra2-targeted radioimmunotherapy for glioblastoma

PROJECT ABSTRACT
Interleukin-13 receptor alpha-2 (IL13Rα2) is expressed with high frequency and specificity on some of the most
aggressive and deadly cancers such as glioblastoma (GBM), basal-like triple-negative breast cancer, and
metastatic colorectal cancer. GBM is a highly aggressive primary brain tumor with dismal prognosis; its infiltrative
nature makes it difficult to detect and eliminate disseminated cells, and their high mutagenic potential increases
resistance to conventional treatment regimens. In GBM, IL13Rα2 is expressed on bulk and glioma stem cells,
which are generally resistant to cytotoxic therapies, leading to treatment failure and tumor recurrence.
Radioimmunotherapy (RIT) has the potential to address this critical problem, as it offers specific targeting of
cytotoxic radioisotopes while sparing normal tissues, thus enabling delivery of tumoricidal radiation doses to
multiple dispersed sites. IL13Rα2 is a cell surface receptor expressed on highly malignant tumors with negligible
expression in normal tissues, which limits potential side effects from off-site targeting and makes it an ideal target
for RIT. Radiation from RIT induces cell kill when DNA is damaged beyond the capacity of the cell to repair. Beta
(β) particles have a long range of deposition in tissues, usually many cell diameters. This is advantageous for
killing tumors, which exhibit heterogenous antigen expression. 177Lu is a beta-emitting isotope currently used in
commercial products, but 161Tb has demonstrated superior anti-tumor efficacy compared to 177Lu in preclinical
and early clinical investigations since its decay results in the release of β-emitter as well as Auger-electrons,
which may lead to higher tumor-absorbed doses than with 177Lu. Targeted α-therapy with 225Ac (α-emitter) is
ideal for localized cell kill due to its limited range in tissue. It is effective even in hypoxic tumor regions. So far,
however, no radiolabeled agent targeting IL13Rα2-positive malignancies is clinically available. To overcome this
limitation, we have isolated human monoclonal antibodies that specifically bind IL13Rα2 with picomolar affinity.
The primary objectives are to establish a radiotheranostic approach for IL13Rα2-expressing GBM. We will
perform in vitro assays including saturation binding assays with the radiolabelled antibodies to validate target
specificity, assess binding kinetics, and to determine stability, cell-level radiation toxicity, and dosimetry.
Furthermore, we will develop a radiotheranostic approach in orthotopic xenograft mouse models of GBM
(including PDX model) and compare RIT with 177Lu vs. 161Tb vs. 225Ac. Systemic and locoregional delivery will
be explored. Developing an RIT approach using a human antibody that binds to IL13Rα2-expressing cancer
cells with high affinity and specificity will significantly expand the therapeutic potential for the treatment of GBM
and other hard-to-treat malignancies, such as basal-like breast and colorectal cancers.
MSK’s facilities and team with expertise in the successful development of novel radiopharmaceuticals, clinical
translation, and obtaining FDA approval will ensure the feasibility and applicability of this technology.

Public health relevance
PROJECT NARRATIVE Glioblastoma is a highly aggressive primary brain tumor with dismal prognosis in which interleukin-13 receptor alpha-2 (IL-13Rα2) is expressed on bulk and glioma stem cells, which are generally resistant to cytotoxic therapies. Radioimmunotherapy has the potential to address treatment failure and tumor recurrence, as it offers specific targeting of cytotoxic radioisotopes while sparing normal tissues, thus enabling delivery of tumoricidal radiation doses to multiple dispersed sites. We propose to develop a novel radioimmunotherapy approach using a humanized antibody that binds to IL-13Rα2-expressing cancer cells with high affinity and specificity, which will significantly enhance the therapeutic potential for the treatment of glioblastoma and other hard-to-treat malignancies, such as basal-like breast and colorectal cancers.